Preventing UV-induced immunosuppression and skin carcinogenesis with R-carvedilol

Skin cancer, particularly non-melanoma skin cancer, is by far the most common malignancy in the US.
Overexposure to ultraviolet (UV) radiation is a main factor causing skin cancer, via inducing DNA damage,
inflammation, and immunosuppression. The β-adrenergic receptor (β-AR) antagonist (β-blocker) carvedilol, a
commonly used drug for cardiovascular disorders, has shown promising activity in preventing UV-induced skin
cancer in vitro and in vivo. However, as a highly potent β-blocker, systemic absorbtion of carvedilol may cause
unwanted cardiovascular effects such as bradycardia and hypotention. To overcome this obstacle, two strategies
are applied: (1) development of a skin targeting nanodelivery system, and (2) examination of the effects of the
non-β-blocking R-carvedilol enantiomer, because carvedilol is a racemic mixture consisting of the β-blocking S-
carvedilol and non-β-blocking R-carvedilol in 1:1 ratio. Preliminary data indicate that topical delivery of
carvedilol loaded nano-transfersome was able to effectively prevent skin cancer without systemic absorption.
Additional data indicate that β-blockade is dispensable for carvedilol's cancer preventive activity. Further
preliminary studies indicate that R-carvedilol, although not a β-blocker, is effective in preventing UV-induced
immunosuppression and skin carcinogenesis without affecting blood pressure. Importantly, both R- and S-
carvedilol inhibit ryanodine receptors (RyRs) by reducing the opening time of this intracellular calcium channel,
and further preliminary data suggest that reducing RyR opening activity represents a previously unexplored
mechanism for skin cancer prevention. Thus, the overall objective of this application is to determine the
molecular target for carvedilol-mediated chemoprevention and examine a novel nanodelivery system of R-
carvedilol as an effective and safe approach for skin cancer prevention. Aim 1 is to test the hypothesis that
carvedilol prevents cancer independently of β-blockade. Aim 2 is to test the hypothesis that reducing RyR activity
mediates carvedilol's cancer preventative activity. Aim 3 is test the hypothesis that R-carvedilol can be
formulated in nano-transfersome gel which can be safely and repeatedly applied to the skin without significant
systemic absorption. Since carvedilol is an FDA-approved agent, we anticipate the outcomes from this project
will be readily translated into a cancer preventive regimen for healthy human subjects or individuals with
weakened immune system. Importantly, R-carvedilol, lacking β-blocking activity, is expected to prevent cancer
without cardiovascular disturbance, and therefore should be an excellent drug for skin cancer chemoprevention.

Public health relevance
Overexposure to UV radiation causes skin damage, inflammation, defective immunity, and development of skin cancer, which is the most common cancer in the US and the world. The β-blocker carvedilol prevents UV-induced skin cancer by attenuating DNA damage and skin inflammation and reversing immunosuppression, and our recent data indicate that the non-β-blocking enantiomer R-carvedilol shows the same effects without disturbing the cardiovascular system. Studies are proposed in this application to determine the molecular target, safety and delivery of R-carvedilol, which will not only provide valuable information about repurposing a β-blocker as a topical prophylactic medication for cancer, but also lead us to identify new targets for cancer chemoprevention.